Molecular targets of the anti-apicomplexan compound, tartrolon E

ABSTRACT:
Development of effective and robust treatments for diseases caused by apicomplexan parasites is an ongoing
medical and veterinary challenge. Since natural products are a proven source of effective and robust
therapeutics against parasitic infections, we mined marine sources for anti-Toxoplasma and
anti-Cryptosporidium activity. These screens identified a marine natural product, tartrolon E (trtE), with broad
anti-apicomplexan activity in vitro and in vivo. Repeated attempts to select trtE-resistant T. gondii or P.
falciparum mutants were unsuccessful implying that conservation of the trtE target is essential for parasite
viability. To identify the target of trtE, we conducted a drug affinity response target stability (DARTS) assay.
Proteins that were protected from proteolysis by the presence of trtE were identified by quantitative mass
spectrometry. Two rhoptry proteins were highly enriched in trtE treated samples, TgROPLMF, and TgROP14.
Both proteins are integral membrane proteins with a lipase maturation factor (LMF) domain. LMF-domain
containing proteins are present in most all apicomplexans (ortholog group OG6_106580) consistent with trtE’s
broad spectrum activity. The only apicomplexan lacking an obvious ortholog for the LMF domain containing
proteins is Cryptosporidium. Our preliminary data lead us to hypothesize that TgROPLMF and TgROP14 are
targets of trtE’s activity, and that trtE’s inhibition of the LMF domain proteins has downstream effects on
proteins that interact with TgROPLMF. We will test these hypotheses through the completion of the following
aims. Aim 1: To determine if the LMF domain proteins mediate the anti-parasitic activity of trtE:
Toxoplasma parasites lacking TgROPLMF1, TgROP14, both proteins, or parasites overexpressing
TgROPLMF, will be generated, validated and characterized. The susceptibility of the recombinant parasites to
trtE, as compared to wild-type parasites, will be quantified in assays that evaluate inhibition of invasion and
intracellular replication. Aim 2: To identify the interactome of TgROPLMF and TgROP14 and evaluate
trtE’s ability to disrupt the TgROPLMF interactome. The interactome of the LMF domain containing proteins
will be identified by proximity labeling with TurboID. Interacting proteins will be validated by endogenous
tagging and tracking in wild type and recombinant parasites, and the ability of trtE to alter the TgROPLMF
interactome tested. Aim 3: Identify putative trtE targets in Cryptosporidium parvum. Cryptosporidium is
the only apicomplexan susceptible to trtE that lacks LMF domain proteins. In this aim our DARTS strategy will
be repeated with sporozoites to identify putative targets in C. parvum. If the LMF domain proteins are trtE
targets, we will have identified eminently druggable targets common to apicomplexan pathogens, providing
lead compounds for new therapeutic strategies for diseases caused by apicomplexan parasites.

Public health relevance
Project Narrative Apicomplexan parasites are responsible for many globally distributed diseases. Tartrolon E is a compound that kills multiple apicomplexan parasites. In these studies, we will identify how this drug kills parasites so that broad spectrum drugs can be designed.